Community Engagement Core

PROJECT SUMMARY – Community Engagement Core
Communities in New Mexico are exposed to environmental toxicants in the air, water and soil and this includes
rural communities with limited access to resources that can intensify the impact of these environmental
exposures. Native American communities have led the way in sharing and addressing environmental health
concerns in partnerships with UNM researchers, based on multi-directional communication that advances
environmental health science (EHS) responsiveness to the most urgent health needs of local communities.
The aims of the New Mexico Integrative Science Program Incorporating Research in Environmental Sciences
(NM-INSPIRES) Community Engagement Core (CEC) are to 1) translate research and enhance environmental
communication and environmental health literacy; 2) increase community-responsive environmental
health research through multi- directional communication with community stakeholders; and 3) enroll
community stakeholders and researchers in communication and training to build capacity and
enhance community-academic partnerships. We will co-create and implement communication
dissemination plans for multi-modal outreach strategies, including print, digital, and social media
materials in plain language, visual arts for STEM-related environmental health messaging, community
events to bridge the communication gap and ensure a well targeted, multidirectional
impactful flow of information meaningful to New Mexico communities. We will ensure NM-INSPIRES’
responsiveness and relevance to community priorities through multi-directional interactions
among researchers and community stakeholders. We will communicate community concerns to
researchers and facilitate community-engaged research. We will increase enrollment of community
stakeholders and researchers in communication to build capacity and enhance community-academic EH
partnerships. We will design, adapt, integrate and evaluate evidence-based communication workshops for
community and academic partners, journalists and clinicians to build a common framework of understanding
and foster the strong relationships needed for true multi-directional communications. NM-INSPIRES is uniquely
positioned to lead EH community engagement by drawing on our long-standing partnerships that are
respectful of the local residents by integrating core values, beliefs and practices into research programs. Our
long-term goal is to secure an effective, ongoing community-academic partnership that engages our NM
communities in environmental health exposure research and translation, including environmental health
literacy and risk prevention.